Statistical Methods for Prospective Evaluation of Biomarkers

Summary/Abstract
The overarching theme of this project is to develop novel statistical approaches for designing and analyzing
biomarker discovery and validation studies. We consider here prospective studies in clinical settings where
risk markers are used for disease surveillance and prognosis. Motivated by our collaborative research in
the cancer biomarker ﬁeld, we plan to address several new challenges in prospective marker evaluation.
For many cancers, disease outcomes may be heterogeneous due to the multi-focal nature of the disease.
The speciﬁc prediction of the risk of developing aggressive cancer as opposed to indolent cancer is of
great clinical interest, yet it is analytically challenging. In Aim 1 we plan to develop statistical tools for risk
stratiﬁcation and individualized treatment rules in a population with a mixture of indolent and aggressive
cancers. Aim 2 will address complications in disease outcome ascertainment. Efﬁcient and unbiased
estimation procedures will be developed to quantify the prognostic and predictive accuracy of biomarkers.
These methods will be developed in the presence of interval censored data and surveillance-triggered
outcome ascertainment and imperfect or surrogate outcome measurements. Finally, we will derive novel
criteria for model selection with longitudinal data and develop novel approaches for deriving and validating
dynamic surveillance regimens for disease monitoring. The proposed methods will be tested in a wide
range of practice settings in cancer biomarker studies, including stratifying breast cancer survivors in risk
of second primary breast cancer; developing and evaluating optimal biopsy interval regimen in the active
surveillance of prostate cancer; accommodating surveillance-triggered outcome ascertainment schemes;
and making treatment decisions among patients who are at high risk for liver cancer, or colorectal cancer
recurrence.

Public health relevance
Project Narrative Our research program aims to equip biomarker and medical researchers with statistical tools that can enhance the power and rigor of scientific effort aiming to translate knowledge gained from laboratory studies into medical practice. In this cycle, we will address the challenges in outcome ascertainment from prospective cohort studies and propose methods for deriving and validating dynamic surveillance regimens for disease monitoring with multiple biomarkers. The applicability of the proposed methods will be tested in a wide range of practice settings in cancer biomarker studies and integrating our research into clinical settings will help improve survival outcomes and reduce the burden of diseases.